Weight Stigma among Doctoral Clinical Psychology Students: Examining Change and Testing Underlying Mechanisms.

Project Summary/Abstract
Weight stigma is a modifiable risk factor that negatively impacts the health and well-being of higher-weight
people and those with lower BMI who simply perceive themselves as heavy. Weight stigma leads to poorer
health outcomes due to stress processes, lower quality healthcare provision, and healthcare avoidance by
patients to avoid stigma. Psychologists play a large role in behavioral health programs, as well as care for
eating disorders, body dysmorphia, and other conditions that make it essential that they are able to
effectively communicate with higher-weight people in a non-stigmatizing way. Weight stigma is a major risk
factor for psychological disorders and weight stigma is prevalent among mental healthcare providers.
Evidence from studies in medical education suggest that training in healthcare disciplines may reinforce
and increase weight stigma. It is necessary to provide training to future clinical psychologists in patient -
centered communication strategies about body image, weight, weight-inclusive care, and to eliminate
common weight-related biases and stereotypes that will affect care quality. Although clinical psychologists
play an important role in healthcare, it is not known how weight stigma changes during training, if doctoral
training perpetuates weight stigma over time, and if theoretically- and empirically-supported mechanisms
underlying the development of weight stigma apply in clinical psychology settings. The long-term goal of
the proposed research is to examine changes in weight stigma among psychology trainees during four
years of doctoral clinical training. The aims of this study are to 1) establish whether weight stigma changes
as a function of time in doctoral clinical psychology training and 2) identify mechanisms underlying the
development of weight stigma during doctoral clinical training. Given that weight stigma is rarely
addressed in clinical psychology training programs, it is hypothesized that weight stigma will intensify
during time in clinical training. In addition, it is hypothesized that weight controllability beliefs, quality of
intergroup contact with higher-weight people, and perceived social acceptability of weight stigma will
mediate the effect of time in clinical training on weight stigma. This study will use a prospective cohort
longitudinal design and online survey methodology collecting four waves of data across four years of
training from students enrolled in APA-accredited doctoral clinical psychology programs. Longitudinal
mediation methods will be used to examine how processes unfold over time and the temporal order of
events. The proposed research will yield novel insights to inform more effective weight stigma reduction
interventions and the development of training competencies to address weight stigma and provide weight-
inclusive healthcare training. This project will provide the foundation from which to comprehensively
address a long-standing call to increase preparedness of future mental health professionals and improve
the quality of care for people of all sizes.

Public health relevance
Project Narrative Weight stigma is pervasive and harmful; it contributes to poorer physical and mental health outcomes due to stress processes, lower quality care from healthcare providers, and avoidance of healthcare services by patients. Psychologists play a large role in behavioral health programs, as well as care for eating disorders, body dysmorphia, and other conditions that make it essential that they are able to effe ctively communicate with higher-weight people in a non-stigmatizing way. This research seeks to examine how weight stigma changes among students in doctoral clinical psychology programs and the mechanisms underlying the development of weight stigma over time to inform training activities to reduce weight stigma and increase the preparedness of future mental health professionals to provide high-quality care to patients of all sizes.